Preclinical Cardiovascular Disease among Adolescents and Young Adults in Haiti

PROJECT SUMMARY
Dr. Lindsey Reif is a global health epidemiologist with a career goal to leverage epidemiologic research to
implement high-impact health interventions for adolescents and young adults living with HIV (AYALH). Over
the past decade, she has published 10 first-author papers focused on evaluating health outcomes and
interventions among AYALH in Haiti. AYALH, who have survived decades of HIV, now face HIV-related
comorbidities, specifically cardiovascular disease (CVD), as they age into adulthood. Her K01 objective is to
expand her training and research to focus on HIV-related preclinical CVD— asymptomatic cardiometabolic
abnormalities indicating the onset of CVD—among AYALH. She will adapt evidence-based interventions to
prevent early onset CVD with impact for AYALH across the lifecourse.
Her training objectives are to build expertise in: 1) CVD epidemiology among AYALH, 2) mixed-methods,
and 3) implementation science in order to design and implement interventions to prevent CVD morbidity and
mortality. Her career development plan includes multidisciplinary mentorship from a team that brings
decades of experience in research among AYALH, HIV and CVD epidemiology, and implementation science
across global health settings. The team has an impeccable track record of mentorship in global health
research. Dr. Reif will also take complementary advanced coursework to support her training objectives. Her
K01 is supported by a robust research and training environment that leverages a 40-year collaboration
between Weill Cornell (New York) and GHESKIO (Haiti).
Dr. Reif’s research plan establishes the epidemiology of preclinical CVD among AYALH and adapts an
evidence-based intervention to prevent the onset of preclinical CVD and its progression. She will conduct a
prospective cohort study among 500 HIV+ and 500 HIV- participants ages 18-30 years, followed for 3 years in
Haiti. In Aim 1, she will evaluate the prevalence, age of onset and progression of preclinical CVD (pre-
hypertension, microalbuminuria, and dyslipidemia) by HIV serostatus. She will evaluate risk factors in 3
domains: lifestyle, HIV-related, and psychosocial. She hypothesizes clusters of risk factors, driven by HIV-
related and psychosocial factors, are associated with preclinical CVD among AYALH. In Aim 2, she will adapt
the evidence-based WHO HEARTS technical package for AYALH in LICs using mixed methods and
implementation science. This K01 addresses the knowledge gap of the epidemiology of preclinical CVD among
AYALH and informs the adaptation of evidence-based CVD interventions to prevent premature disability and
death among this population as they emerge into adulthood. Dr. Reif’s training and career development plan
complement and expand her existing skillset and culminate in the submission of an NIH R01 facilitating her
transition to independent investigator.

Public health relevance
PROJECT NARATIVE There are nearly 5 million adolescents and young adults living with HIV (AYALH) globally who have survived growing up with HIV and are now emerging into adulthood to confront high rates of HIV-related co-morbidities including preclinical cardiovascular disease (CVD) which is associated with premature death and disability. The epidemiology of preclinical CVD among AYALH is not defined, including age of onset, progression, and associated risk factors. In this K01 proposal, Dr. Reif will conduct a prospective cohort study of 500 HIV+ and 500 HIV- participants ages 18-30 years in Haiti followed for 3 years to address this knowledge gap and inform the adaptation of evidence-based CVD interventions for AYALH and for integration into HIV clinics.